The Role of HIF2 in Pancreatic Ductal Adenocarcinoma

PROJECT SUMMARY/ABSTRACT
Per the additional NCI guidelines for PA-21-01, the parent grant abstract is uploaded as part of the six-page
requirement for Research, Mentoring, and Career Development Plan.

Public health relevance
PROJECT NARRATIVE Project Narrative is not requested. This is an NCI Diversity Supplement to Dr. Cullen Taniguchi’s grant (R01CA269565), titled, The Role of HIF2 in Pancreatic Ductal Adenocarcinoma.